NH PHL Discipline A Microbiology Analytical Track 2 - human food product testing

Discipline A: Microbiology Analytical Track 2: Human Food Product Testing To improve food testing surveillance programs through the microbiological analysis of food products and environmental samples. The test results generated by these laboratories can be used to remove adulterated food from commerce and aide regulatory inspection programs in conducting investigations. The NH PHL plans to test ready to eat products for Salmonella, pathogenic E. coli and Salmonella over the course of the 5-year grant period. The NH PHL will start with 250 samples of a single commodity/hazard pair, the commodity will be ready to eat products collected by trained community Health Officers, the NH PHL will test for pathogenic E.coli. During the 5-year grant period the NH PHL plans to expand testing to additional matrices and organisms. NH PHL will participate and pass annual proficiency tests, attend the LFFM Face-to-Face meeting and monthly calls, maintain ISO 17025 accreditation, maintain facilities and personnel necessary to complete the work proposed, and provide a detailed quarterly summary of all samples collected and analyzed. The NH PHL will maintain a valid 20.88 agreement with the FDA.

Public health relevance
Project Narrative Track 2 – Human Food Product Testing The project activities of the New Hampshire Public Health Laboratories (NH PHL) will improve food testing surveillance programs in the State of New Hampshire and nationwide through the microbiological analysis of food products and environmental samples. The test results generated by this project will be used to remove adulterated food from commerce and aide regulatory inspection programs in conducting investigations.